Defining Prenatal Alcohol Exposure Impact on Frontoparietal Signaling During Cognitive Control

Project Summary:
Consumption of alcohol during pregnancy results in the development of fetal alcohol spectrum disorders
(FASD), which is conservatively estimated to affect 5% of United States first graders. Individuals with FASD
often report difficulties with executive function domains including cognitive control, which is the ability to
maintain goal-directed behavior despite distractions. Such cognitive control deficits have been replicated in
mouse models of prenatal alcohol exposure (PAE); however, the electrophysiological underpinnings of these
deficits are not understood. To fill this knowledge gap, I propose to investigate the underlying
electrophysiological mechanism(s) of PAE-associated cognitive control deficits by combining translational
touchscreen testing and in vivo electrophysiology with a first- and second-trimester equivalent moderate PAE
paradigm. My central hypothesis is that PAE induces long-term impairments in cognitive control by reducing
parvalbumin fast-spiking interneurons in the posterior parietal cortex (PPC), which results in an inability to gate
incoming excitatory signaling in frontoparietal circuits required to exert cognitive control. Electrodes will be
implanted into the PPC and medial prefrontal cortex (mPFC), allowing data collection during the 5 Choice
Continuous Performance Task (5C-CPT). 5C-CPT is a translational touchscreen paradigm that assesses many
domains of executive function, including cognitive control. Multiple analytic tools will be used to investigate the
impact of PAE on the excitatory/inhibitory balance and oscillatory signaling of the PPC. Additional tools will be
used to determine if PAE dysregulates frontoparietal signaling via decreases in synchronous activity between
the mPFC and PPC. Collectively, this proposal will determine the impact of PAE on electrophysiological
functions in both the PPC alone and the mPFC-PPC reciprocal circuitry during trials taxing cognitive control.
The successful completion of this proposal will provide crucial information on the lasting neurological impacts
of moderate PAE on individual neurons and oscillations in both the PPC and the reciprocal mPFC-PPC
circuitry. Additionally, this work will provide intensive training in awake-behaving high-yield electrophysiology,
translational touchscreen behavior, and complex data analysis.

Public health relevance
Project Narrative: Consumption of alcohol during pregnancy results in the most common preventable birth defect, fetal alcohol spectrum disorders (FASD). Executive dysfunction is consistently found in individuals across the FASD spectrum, making it a core feature of these diseases. By using a mouse model to investigate the underlying mechanisms of these deficits, the successful completion of this proposal will provide valuable information that will inform future research and therapeutics.